Project 4-Monika Rak

Abstract: Glial tumors are the most commonly occurring malignant brain tumor in the United
States, among which approximately 20% are glioblastomas, which are the most aggressive and
practically incurable. Drug resistance is often associated with the existence of a discrete
population of cells, which demonstrate a stem-like phenotype. In glioblastoma, these cells are
known as glioma initialing cells (GICs), and their expansion is often linked with tumor recurrence.
Human endogenous retroviral sequences (HERVs) are mobile elements of the viral origin that
comprise nearly 8% of the human genome. In HERVs, like in all retroviruses, genes encoding
viral proteins are flanked by long terminal repeats (LTRs). Serving as promoters, LTRs are
particularly enriched in binding motifs for transcription factors. Importantly, recent studies show
that HERV transcripts are upregulated during early human development, including CNS
development, when cellular pluripotency and stem-like phenotype predominate. Reactivation of
HERV loci are also associated with different tumors, however, the cause and effect relationship
between HERVs and cancer have not been established. Therefore, the effect/s of HERVs on the
development and maintenance of stem-like phenotype in glioblastoma tumors, and the associated
drug resistance, require further investigation. We hypothesize that aberrant expression of HERVs
found in glioblastoma clinical samples contributes to the enhanced glioblastoma stem-like
phenotype and associated drug resistance. We will test this general hypothesis by executing our
experimental plan that consists of two independent but logically connected Specific Aims: In Aim
1 we will determine HERV transcript levels in glial tumors, and analyze if high HERV transcription
correlates with: a) specific glioblastoma subtype: pro-neural (17 months survival), classical (14
months survival), mesenchymal (11.5 months survival), as compared to low-grade gliomas (90%
curable); b) glioblastoma stem-specific transcription pattern. In Aim 2 we will analyze effects of
inducible Crisp/Cas-based -upregulation and -downregulation of HERV transcripts on stem-like
phenotype and malignant growth of low grade gliomas and glioblastomas, respectively. The long-
term objective is to establish the role of HERV transcripts in establishing highly malignant
phenotype of glioblastoma, and to use this knowledge in the development of new therapeutic
strategies against these terminal brain neoplasms.